Generation of Neurons by Force-Mediated Epigenetic Mechanisms through Manipulation of Intrinsic Mechanoregulators

PROJECT SUMMARY
There is a great interest in deriving induced neuronal (iN) cells from human pluripotent stem cells (hPSCs) for
central nervous system disease modeling and drug discovery. However, current differentiation methods are
laborious and inefficient, thus, identifying new ways to improve neuronal differentiation is desirable. Strikingly, in
my most recent publication I discovered that knockout of the axon guidance receptor Plexin-B2 in hNPCs
reduced cell stiffness, increased Yes-Associated Protein 1 (YAP) phosphorylation, and accelerated neuronal
differentiation. As a critical downstream mechanism, my preliminary data points to a pathway of Plexin-B2 altered
mechanoregulation affecting lamin-mediated nuclear envelope architecture and localization of repressive histone
marks at genomic loci containing neuron-specific genes.
Based on these data, I will investigate an intrinsic ‘force-based’ method to generate iNs by manipulating
Plexin-B2, Angiomotin (AMOT; a mechanosensitive component of Hippo pathway), and YAP in both 2D and 3D
neuronal cultures and examine the link between Plexin-B2 and Hippo/YAP mechano-signaling in regulating
lamin-mediated nuclear physical properties, force transmission to the nuclear envelope, and changes in
chromatin accessibility during neural induction. To carry out this investigation, I propose the following aims: #1.
Investigate the impact of Plexin-B2-altered cell mechanics on neuronal differentiation, by optimizing the
differentiation method to generate iNs by both Plexin-B2 knockdown and knockout in multiple hPSC lines. I will
test the robustness, stability, and functionality of iNs by evaluating transcriptional identity, neuronal lineage,
maturation, and survival markers, electrophysiological properties, and neurotransmitter release. #2. Investigate
a mechanochemical loop between Plexin-B2 and YAP during neuronal differentiation, by performing a
comprehensive gain- and loss-of-function epistasis studies to map out the relationships between Plexin-B2, YAP,
and AMOT during neural induction and evaluate their impact on enhancing neuronal differentiation, maturation,
survival, electrophysiological functionality, and expression of major neuronal lineage markers. #3. Investigate
lamin-mediated nuclear architecture and chromatin interactions in Plexin-YAP mechano-regulation of
neuronal differentiation, by performing a comprehensive gain- and loss-of-function epistasis studies to validate
lamin as the mediator of a Plexin-B2 and Hippo/YAP intrinsically-regulated mechano-axis to promote neuronal
differentiation. I will then evaluate the role of Plexin-B2 / Hippo/YAP / lamins in releasing genomic loci harboring
neuron-specific genes from repressive chromatin at nuclear periphery to interior regions with open chromatin.
This K01 Award will provide me training in neuronal electrophysiology, transcriptomics and epigenomics,
lab management and mentoring skills, as well as time and mentoring to develop and write my first NIH-R01.
My long-term goal is to investigate new mechano-responsive elements (MREs) underlying cell fate choices to
generate specific iNs for disease modelling and potential cell replacement therapy for neurological diseases.

Public health relevance
PROJECT NARRATIVE Generation of induced neuronal (iN) cells from human pluripotent stem cells (hPSCs) offers great potential for central nervous system (CNS) disease modeling and drug screening, however, current differentiation methods are often laborious, time-consuming, and inefficient. It is increasing clear that mechanical forces provide overarching signals for cell fate choice, but how the mechanochemical signaling transmit to the nucleus and alters the chromatin structure is unclear. Here, I propose to investigate a novel intrinsically-regulated mechano- signaling pathway impact on the nuclear organization of the genome to promote neuronal differentiation, which besides advancing fundamental understanding of neuronal lineage specification, this project will establish a new ‘force-based’ method for the generation of iNs, thus facilitating hPSC-based strategies to model and potentially to treat CNS diseases.